Resolving Methodological Challenges in Genomics Research: Causality, Risk Prediction, and Reproducibility: Administrative Supplement

Project Summary This proposed project focuses on the statistical assessment of reproducibility in genomic and genetic applications. Reproducibility is a hallmark of scientific research. However, the quantitative tools for evaluating reproducibility and replicability are still lacking. We will develop and apply computational tools to assess reproducibility in findings from genetic and genomic research. We will build user-friendly computational software packages and make them available to the broad community of biological and medical scientists.

Public health relevance
Project Narrative Public health relevance: This is project will develop and apply computational tools for analyzing large-scale data from genomic and complex disease studies to gain understanding the molecular mechanisms of complex diseases, Additionally, the project will develop computational tools to aid improving reproducibility of biomedical research. All three aspects are fundamental in complex disease studies, where the knowledge will eventually lead to new and reliable treatment strategies.